DREF Research Matters: Creating Possibilities to Achieve Health and Wellness for All of Us Through Community and Researcher Engagement, Enrollment and Retention

Project Abstract
The purpose of the DREF Research Matters: Creating Possibilities to Achieve Health and Wellness
for All of Us Through Community, Historically Black Colleges and Universities and Researcher
Engagement, Enrollment and Retention project is to help All of Us build a cohort of volunteers who
reflect the rich diversity of the United States and are actively engaged as partners. DREF will
contribute to the building of the national research dataset by engaging and educating African
American adults, particularly parents of school-aged children, on the benefits of biomedical
research and participation in clinical trials. These individuals and communities will be encouraged
to enroll in the program. DREF will also share information on the All of Us Research Hub and
Researcher Workbench with researchers from diverse backgrounds and encourage use of the
dataset for multidisciplinary research projects.